Tin-Silver Alloy as a Degradable Biomaterial: Biocompatibility Assessment

Project Summary/Abstract
A component of the Essure® Micro Insert Female Sterilization device is comprised, in part, of a tin-silver (Sn-Ag)
solder, a metal alloy which had never been previously implanted into the human body cavity and for which there is little
to no peer-reviewed scientific literature of its use in the human body. The Essure® insert received premarket approval
from the US Food and Drug Administration in 2002 as a non-surgical, non-hormonal alternative to tubal ligation. The
device utilized dacron fibers to initiate a fibrotic immune reaction occluding the fallopian tube over the course of three
months. These fibers were held in place with a 316L Stainless Steel coil (SS), and soldered with Sn-Ag to an outer, shape
memory Nickel-Titanium coil (Ni-Ti), which expanded to the diameter of the fallopian tube. Additionally, two platinum-
iridium (Pt-Ir) radiopaque markers were on the coils to assist in the insertion process. After only about 15 years on the
market, the patient-reported adverse events rose rapidly, resulting in an FDA-mandated 522 post-market surveillance
study and the voluntarily withdrawal of the implant from the global market by Bayer Healthcare. To investigate the failure
of the device, several retrieval analyses were performed by our lab. While the device was intended to remain permanently
implanted in Essure®, these investigations demonstrate evidence that Sn-Ag is a degradable alloy, where severe corrosion
of the Sn-Ag solder resulted in fragmentation of the device as well as the release of oxides, chlorides, and phosphates into
surrounding tissue. We observed that Sn-Ag corrosion in vivo induced a densely fibrotic tissue response where fibrous
tissue grew into and became strongly attached to the porous metal. These observations led us to hypothesize that Sn-Ag
may be used as a beneficial degradable alloy that can induce fibrous tissue attachment to metal surfaces. In the current
R03 proposal we seek to explore the biological interaction of this biodegradable Sn-Ag alloy and assess its
biocompatibility. This basic information is lacking in the biomaterials literature and will provide a basis for consideration
of Sn-Ag as a degradable metallic biomaterial. Due to the lack of scientific peer reviewed work regarding the use of
Sn-Ag as a biomaterial or its behavior in vivo, this proposal aims to 1. Assess the material for cytocompatibility in
vitro and 2. Assess the material/tissue interface in vivo using an animal model. An assessment of cytocompatibility
following exposure to various concentrations of corrosion products will allow for a deeper understanding of the local
effects caused by implantation of the biomaterial. Compared to the ex vivo retrieval investigations, an animal model will
allow for greater understanding of the blood metal ion concentrations over implantation time, systemic effects, and
provides an opportunity to better assess the possibility of stimulating fibrous tissue ingrowth as seen in the human
retrievals. Due to the usefulness of Sn-Ag as a solder in contact with other alloys, evaluating the alloy on its own as well
as in conjunction with an additional metal alloy will provide more translation into real-world applications as a degradable
metallic biomaterial. This work will provide insight and understanding of current phenomena experienced by women with
Essure®, as well as provide insight into novel applications for Sn-Ag as a degradable metallic biomaterial.

Public health relevance
Project Narrative: Tin-Silver (Sn-Ag) alloy has been used in hundreds of thousands of implanted Essure medical devices to impart female sterilization with little to no peer-reviewed scientific literature published on the corrosion or biocompatibility of this solder. Studies of Essure devices retrieved from patients by our laboratory have shown both significant corrosion of the Sn-Ag solder and a tenacious fibrous tissue ingress and attachment to the Sn-Ag corroding surface. This R03 proposal seeks to address the gap in our knowledge of the biocompatibility of Sn-Ag in both cell culture and a 26 week rat animal model compared to other medical alloys and to begin to assess the fibrous tissue attachment capability of this alloy for potential applications where strong fibrous tissue (e.g., tendon or ligament) attachment to metallic implants is desired, for example, such as in reconstruction after osteosarcoma.